Base editing to elucidate RAF regulation and signaling

Project Summary
Mitogen activated protein kinase (MAPK) signaling regulates cell growth in normal cells and is frequently
overactivated in cancer. Within this pathway, RAF kinases are core signaling nodes and are of particular interest
as cancer drug targets. Despite extensive study, RAF kinase function and regulation remain incompletely
understood. Intriguingly, several studies have shown that the expression of CRAF protein but not CRAF kinase
activity is essential for the growth of KRAS mutant lung cancer. To date, only a handful of function modifying
mutations have been used to study CRAF function in this context, and these are often utilized in vitro or in
exogenous overexpression experiments where stoichiometry is non-physiological and native scaffolding factors
are absent. Interpretation of these experimental results can also be complicated by the modular nature of RAF
dimers, and it is seldom clear which RAF homo-/hetero-dimers are responsible for observed cellular phenotypes.
A clearer understanding of CRAF’s oncogenic role, including homo-/hetero-dimer functions, would inform future
efforts to target CRAF in KRAS-driven cancers via inhibition, targeted degradation, or other mechanisms.
This proposal will utilize a combination of unbiased base editor scans and “bump-hole” methodologies to
elucidate the role of CRAF in KRAS-driven cancer and understand the relative activity of various RAF dimers.
Specifically, I will test the hypothesis that CRAF’s role in KRAS mutant lung cancer is to form less active
RAF dimers, diminish downstream signaling, and prevent otherwise toxic levels of MAPK signaling.
Confirming this hypothesis has direct implications for cancer therapeutic development and would suggest that
CRAF degraders but not competitive active-site inhibitors would be effective in this tumor subtype.
This project will also advance fundamental knowledge of RAF kinases and expand the methods used to
study them. In confirming the central hypothesis of this proposal, I will validate the goldilocks premise of RAF
signaling – that too little or too much signaling impedes cancer growth. In aim one, unbiased base editor scanning
paired with rigorous follow-up characterizations will expand knowledge of CRAF’s multiple functions and
interaction partners. In aim two, I will validate a co-mutational approach to reveal the relative contribution of each
RAF dimer to cancer growth and MAPK signaling. This aim also has broad application in cell signaling research
and could constitute a generalizable approach to studying protein homo-/hetero-dimers with conserved
dimerization interfaces.
While advancing knowledge of RAF biology, this fellowship will also provide a rich training environment
across two cutting edge research institutions: Harvard’s department of Chemistry and Chemical Biology and the
Dana Farber Cancer Institute. Training will include regular meetings with my mentors, seminars with relevant
scientific experts, and opportunities to present my research internally and externally. Mentorship provided by
Brian Liau and Andrew Aguirre will greatly facilitate my development as an independent cancer researcher.

Public health relevance
Project Narrative Developing effective targeted therapies for cancer requires an accurate understanding of the proteins that sustain cancer growth, but some of these proteins can have multiple, and even unexpected functions. This proposal will investigate the multiple functions of CRAF, a key protein that sustains growth of a subset of lung cancers, but whose molecular function(s) remain contested. The discoveries made in this study will inform cancer drug development efforts by revealing how CRAF promotes tumor progression and how CRAF can be targeted to selectively kill cancer cells.